Time restricted eating for prevention of age-related vascular cognitive decline in older adults

PROJECT SUMMARY/ABSTRACT
Cognitive impairment associated with Alzheimer’s disease and Related Dementias (ADRD) and aging has
emerged as one of the major public health challenges of our time. Recent clinical studies, as well as those in animal
models, support that preservation of cognitive health depends on an adequate cerebral blood flow (CBF) supply to
the active brain regions. Importantly, in the healthy, young brain cerebral blood supply is readily adjusted to meet the
increased oxygen and nutrient demand of activated neurons. This homeostatic mechanism, termed "neurovascular
coupling" (NVC) or "functional hyperemia", is required for normal brain function. Preclinical and clinical evidence
shows that aging per se significantly impairs endothelium mediated NVC responses, which play a causal role in age-
related vascular cognitive impairment (VCI) and the development of ADRD.
Lifestyle factors, including nutrition and dietary habits, significantly affect cerebrovascular health and, thereby,
influence the pathogenesis of age-related cognitive impairment and ADRD. Caloric restriction (CR), which exerts
multifaceted anti-aging and lifespan-extending effects, has been demonstrated to be an effective nutritional
intervention that can improve vascular health and cognitive function. CR activates SIRT1-dependent pathways in the
vasculature, which attenuates cellular oxidative stress and rescues endothelial vasodilation. However, adherence to
CR remains a challenge and a translational barrier as most humans may not be able, or willing, to reduce their caloric
intake by 30% over extended periods of time. Intermittent fasting can recapitulate the benefits of CR without limiting
calorie intake in older adults. Time restricted eating (TRE) is considered the best approach to intermittent fasting for
elderly individuals as it allows consumption of required calories within a condensed daily eating window (4-10 hours),
resulting in the greatest fasting stimulus without a net reduction in calorie intake. Yet, the impact of TRE on
cerebrovascular function and, potentially the delay of ADRD and age-related VCI, to preserve cognition is currently
unknown.
Our central hypothesis is that closer adherence to TRE will improve NVC responses and micro- and
macrovascular endothelial function, potentially through activation of SIRT1-dependent vasoprotective pathways,
resulting in the improvement of cognitive performance. This hypothesis will be tested by assessing the effects of
TRE (10 hours eating window) in community dwelling older adults (55-80 years of age) in a 6-month study. Aim 1 will
determine the impact of TRE on NVC responses using innovative technologies such as functional near-infrared
spectroscopy (fNIRS) and dynamic retinal vessel analysis (DVA), and on microvascular endothelial function using
laser speckle contrast imaging and flow-mediated dilation approaches in community dwelling older adults. Aim 2 will
determine the impact of TRE on circulating biomarkers and cerebromicrovascular endothelial cell SIRT1 activity.

Public health relevance
PROJECT NARRATIVE Normal cognitive function requires an adequate blood supply to support neuronal activity via neurovascular coupling, and recent evidence demonstrates that age-related cognitive decline that manifests in Alzheimer’s dis- ease and related dementias (ADRD) is directly linked to reduced neurovascular coupling (NVC) responses. Caloric restriction exerts multifaceted anti-aging and lifespan-extending effects and has been demonstrated to be an effec- tive nutritional intervention that can improve vascular health and cognitive function, however, adherence to caloric restriction remains a challenge and a translational barrier as most humans may not be able, or willing, to reduce their caloric intake by 30% over extended periods of time. Based on the abundant literature in the field, our pub- lished preclinical results and preliminary data in humans, these series of studies are designed to assess a clinically relevant lifestyle intervention of time restricted eating to improve endothelial function and NVC responses in com- munity dwelling older adults to prevent and, potentially to treat, age-related cognitive decline associated with ADRD.